Glycan-Mediated Impacts on the Mucus Barrier Towards Respiratory Viruses

PROJECT SUMMARY / ABSTRACT
The mucus barrier in the lung provides a critical, first-line defense system that acts to trap and remove inhaled
particulates. To cause infection, viruses must overcome this barrier to avoid elimination from the respiratory tract.
Thus, understanding the elements that constitute a functional mucus barrier and the specific nature of virus-
mucus interactions is paramount. Prior work investigating the mechanisms by which respiratory viruses such as
influenza A virus (IAV) are neutralized by the mucus barrier in the lung has primarily focused on virus trapping
through adhesive interactions. However, our preliminary data suggest penetration of IAV through the mucus
barrier can be largely attributed to the architecture of mucus that leads to viral particle size -dependent physical
trapping. Moreover, it remains unclear how the mucus barrier protects the lung against other respiratory viruses
with and without the capacity to bind mucin-associated glycans. We propose a conceptually innovative central
hypothesis that physical trapping of viruses by the mucus barrier is glycan dependent and provides a broadly
conserved protective mechanism to neutralize diverse respiratory viruses. This hypothesis will be tested by
pursuing two specific aims where we will determine 1) how mucin-associated glycans dictate structural mucus
properties and mucociliary clearance (MCC) and 2) how specific secreted mucins and mucin-associated glycans
dictate virus trapping and infection dynamics by diverse respiratory viruses including IAV, rhinovirus, respiratory
syncytial virus, human metapneumovirus, human parainfluenza virus 3, and adenovirus. To achieve these
objectives, we will utilize genetically-modified models of human airway epithelium lacking specific secreted mucin
proteins, or deficient in fucosylation, sialylation, or sulfation. This approach is technically innovative and will be
paired with biophysical assays to quantify virus-mucus interactions and real-time dynamics of mucus clearance
function to provide mechanistic understanding of observed viral infection phenotypes. Together, this work will
further clarify the impact of mucus, mucins, and their associated glycans on host-pathogen interactions critical
to protection against respiratory virus infection. If successful, the results of this work will be significant given such
knowledge will inform our understanding of viral transmission and susceptibility to infection and provide
mechanistic insights which could potentially explain the deficits in antiviral functions observed clinically in chronic
lung diseases.

Public health relevance
PROJECT NARRATIVE Respiratory viruses comprise a diverse set of pathogens that are responsible for significant morbidity and mortality in the human population. The mucus barrier lining the respiratory tract facilitates trapping and removal of these viruses from the lung; yet, how mucus composition impacts these protective functions and the ability of mucus to mitigate infection by respiratory viruses that differ in size, shape, and glycan-binding properties is not clear. These studies will provide new insights into the nature of virus penetration through mucus important to our understanding of host-pathogen interactions and extracellular innate defense mechanisms with relevance to both healthy and diseased airways.